Metabolism of Carcinogens and Drugs by Human P450s

Cytochrome P450 (P450) enzymes are the major catalysts involved in the metatiolism of carcinogens, drugs, and steroids. Variations in the catalytic activities have a variety of effects in homeostasis and clinical practice. Continued studies on human P450s are proposed, with a focus on molecular understanding of function. (1) Of the 57 human P450 genes, 13 still have limited if any knowledge regarding function. We propose to establish sites of mRNA expression, express these orphan P450s in heterologous systems, and examine their abilities to activate a wide variety of chemical carcinogens. In addition, several HPLC- mass spectrometry approaches will be used for identification of products and substrates, with tissue extracts as sources of substrates and the P4SOs as reagents. This part of the project is an effort towards understanding the functional genomics of human P450s. A related aspect is establishment of the roles of individual human P450s in morphine biosynthesis, forwhich strong evidence has been recently presented by others. (2) Comparisons of the Idnetics of human P450s already studied in detail (1A2, 2A6, 2D6,2E1, 3A4) will be done with several other P450s reported to have much higher rates of catalysis, with the goal of understanding which steps limit the (human P4S0) reactions. These studies will involve a variety of steady-state, pre-steady-state, and isotope effect approaches. (3) Kinetic analysis of multi-reaction P450s will be done, including P450S 51Al (ianosterol 14a-demethylation), 19A1 (aromatase, oxidation of testosterone to 17p-estradiol), and 2A6 (oxidation of indoles), wrth a goal of defining the processivity of these systems. Several pre-steady-state and analysis approaches can be readily applied to the problem, with the goal of understanding the release of intermediates. (4) P450S 3A4 and 2A6 will be analyzed regarding hypotheses about cooperativity and induced fit in substrate binding and catalysis. The P450 3A4 work will focus on pre-steady-state i^inetics of substrate binding, along with thermodynamic analysis of binding. The wori< on P4S0 2A6 induced fit will involve collaborative work on X-ray crystallography of mutants that have demonstrated expansion of the active site. These results should reveal whether a P450 has a fixed structure or can adapt to individual substrates, Collectively, these studies have the goal of providing more understanding of the roles of human P450s in oxidation of drugs, carcinogens, and endogenous compounds and their potential contributions to cancer and other diseases and roles in disease treatments.

Public health relevance
RELEVANCE (See Instructions): The P450 enzymes are the main catalysts involved in the metabolism of carcinogens and daigs, and the balance between bioactivation (to dangerous products) and detoxication is important in health issues and also varies among individuals. Many of the biochemical properties of some human P450s are pooriy understood, and several of these enzymes are postulated to have important roles in chemical carcinogenesis.